Prognostic Study of the Risk Factors for Contralateral ACL Injury

Project Summary
Injuries to the anterior cruciate ligament (ACL) are highly debilitating; each year they affect more than 120,000
individuals in the United States and 1.4 million worldwide. It is estimated that one-third of these individuals will
suffer subsequent truama of the same kind to the contralateral knee or ACL graft. Not only do these injuries
result in time lost from sport and activity, are immediatley disabeling, and typically require surgery, they are
associated with post traumatic osteoarthritis (PTOA) of the knee regardless of the type of treatment that is
chosen. ACL injury and the subsequent sequela of PTOA is debilitating due to its earlier onset in comparison
to idiopathic osteoarthritis (OA), creating a considerable therapeutic concern as a majority of these injuries
occur in active young individuals between 15 and 25 years of age that place high demand on their joints and
consequently require earlier and more frequent surgery and rehabilitation.
During the prior funding interval, we determined the risk factors for a first time ACL tear (please see Progress
Report for details). A subset of the injured athletes from that study were followed after surgery, rehabilitation
and return to sport for 2 years, and 18% went on to suffer a complete disruption of their contralateral ACL
(CACL), and 10.9% suffered a graft injury (total re-injury rate of 28.9%). Rather than treat this trauma and the
subsequent burden of PTOA though surgical approaches, which are only marginally successful, a more
proactive approach is to identify individuals at increased risk of suffering ACL injury and develop injury
prevention programs to mitigate that risk. The investigation in this application is focused on establishing a
complete understanding of the risk factors for a CACL injury. This is an essential next step for understanding
why these injuries occur, the development of prevention strategies that take prior ACL injury into account, and
for identifying those that are at the greatest risk of suffering repeated ACL trauma so they can be targeted for
injury prevention interventions.
The goal of this investigation will be to determine the comprehensive set of risk factors associated with
suffering a CACL following recovery form a first time ACL injury and return to sport/activity. This will be
accomplished by executing the following Specific Aims:
1. To prospectively identify and recruit high school and college athletes who suffer a first-time ACL injury.
2. To measure a comprehensive set of potential risk factors for subsequent CACL injury at the time of the
athlete's return to sport/activity following treatment and rehabilitation. These will include anatomic, strength and
neuromuscular measurements on the contralateral leg, and clinical, demographic, and environmental factors.
3. To follow study subjects over time to identify subsequent non-contact injury to the CACL.
4. To determine combinations of risk factors that are associated with the risk of suffering a CACL injury in
males and females.

Public health relevance
Project Narrative Disruption of the anterior cruciate ligament (ACL) and subsequent injury of the same kind that frequently occurs in the contralateral ACL (CACL) is disabling in the short term and debilitating in the long term due to its association with early onset of post traumatic osteoarthritis (PTOA). During the prior funding cycle, we developed a set of risk factors for identifying individuals at increased risk of a first-time non-contact ACL injury, but it is not known if these risk factors are also predictive of subsequent CACL injury. The necessary next step in the development of comprehensive programs to prevent both initial and subsequent injury is to determine the set of risk factors associated with suffering a CACL following recovery form a first time ACL injury as this will increase the understanding of why ACL injuries occur, inform the development of prevention strategies, and permit identification of those at the greatest risk of suffering repeated ACL trauma so they can be targeted for intervention to reduce their chance of injury.